UNC PREP in Biological & Biomedical Sciences

DESCRIPTION (provided by applicant): The overarching goal of the UNC PREP (UP) is to strengthen the previous training, academic preparation and confidence of underrepresented minority baccalaureates who desire to pursue a PhD in the biomedical sciences but lack one or more qualification needed to be a competitive PhD candidate. Our program will address both collective and individual Scholar weaknesses and support each UP Scholar's transition into highly competitive PhD programs. Scholars will engage in mentored research projects, professional development workshops, graduate level coursework and academic enrichment activities. In addition to preparing each Scholar to be a competitive PhD candidate, we will assist each Scholar in developing a network of mentors and role models who can support their success throughout their scientific career. Public Health Relevance Statement: The long-term goal of the University of North Carolina PREP (UP) in Biological and Biomedical Sciences is to train scientists and researchers who can address our nation's health disparities. The overarching goal of UP is to strengthen the previous training, academic preparation and confidence of young Scholars from underrepresented groups who desire to pursue a PhD in the biomedical sciences but lack one or more qualification needed to be a competitive PhD candidate at a top program.

Public health relevance
Narrative The long-term goal of the University of North Carolina PREP (UP) in Biological and Biomedical Sciences is to train scientists and researchers who can address our nation's health disparities. The overarching goal of UP is to strengthen the previous training, academic preparation and confidence of young Scholars from underrepresented groups who desire to pursue a PhD in the biomedical sciences but lack one or more qualification needed to be a competitive PhD candidate at a top program.